Scaling Up Implementation Strategies to Improve the DIAGNOSE and PREVENT Pillars for Young MSM in Florida

Abstract
This project will launch a Florida wide effort to promote the delivery of developmentally sensitive, culturally
appropriate and evidence-based DIAGNOSE and PREVENT counseling testing and referral services (CTR) for
young men who have sex with men (YMSM). The goal is to leverage implementation science strategies to
improve the capacity of the HIV HealthForce to deliver evidence-based practices (risk reduction counseling,
PrEP referral and Tailored Motivational Interviewing) within CTR services. Our recent YMSM Mystery
Shoppers studies conducted at CTR sites in three cities indicated that providers are woefully unprepared or do
not know how to deliver developmentally appropriate, culturally competent CTR services to YMSM and miss
opportunities to deliver these evidence-based practices. Mystery Shopper is a quality management strategy to
monitor implementation fidelity to culturally and developmentally responsive EBPs in CTR settings. However,
assessment and feedback alone are insufficient to improve fidelity; the HealthForce must be properly trained
and given technical assistance. We propose integrating two implementation strategies: quality management
Mystery Shoppers and HealthForce training in Tailored Motivational Interviewing with centralized technical
assistance. We will test Young Adult Centered HealthForce Training (YACHT) package in Florida’s seven EHE
counties among the Department of Health’s 42 contracted sites who delivered CTR to at least 24 young MSM
in the previous 12 months using a Stepped Wedge design. We power on both effectiveness outcomes (# of
tests of YMSM) and implementation outcomes (EBP fidelity based on Mystery Shopper Assessments)
consistent with a Type 2 Hybrid trial.

Public health relevance
PROJECT NARRATIVE This study will significantly contribute to the field of HIV prevention and treatment by testing an intervention that helps counseling and testing agencies contracted by Florida Department of Health to improve their services to young men who have sex with men.